Defining the role of phosphatidylserine in hemorrhagic fever virus replication

Project Summary
Ebola virus (EBOV) and Lassa virus (LASV) infection is enhanced when cells express phosphatidylserine (PS)
binding receptors on the cell surface. PS is a cellular lipid normally restricted to the inner leaflet, or cytoplasmic
face, of the cellular plasma membrane (PM). The restriction of PS and other phospholipids to the inner leaflet
produces a highly asymmetric membrane in healthy cells. PS is flipped to the outer leaflet of the cellular
membrane during calcium signaling and apoptosis, marking them as activated or dying cells, respectively.
Cellular enzymes termed flippases and scramblases are responsible for flipping the PS in the membrane. PS is
incorporated into the viral membrane during virus budding, when EBOV and LASV particles appropriate a
portion of the host cell's plasma membrane as a protective envelope. In order to engage PS receptors, the PS
on a viral envelope must be flipped to the outer leaflet. We aim to elucidate the mechanism by which viral
envelopes obtain properly oriented PS, as well as the amount of PS sufficient to interact with PS receptors. We
are using a panel of human haploid (HAP1) cell lines lacking PS flippases or PS scramblases to examine the
role these proteins play in the replication of EBOV and LASV. We produced vesicular stomatitis virus
containing either its native glycoprotein (G), LASV-GP, or EBOV-GP, enabling us to perform experiments
under BSL2 conditions. When these recombinant viruses were grown in the HAP1 knock-out cell lines, we
identified one flippase and one scramblase that are required for efficient spread of VSV particles containing
either the LASV-GP or EBOV-GP, but not VSV-G. This data suggests altering the levels of PS in the outer
leaflet of the cellular PM inhibits one or more steps in the viral replication cycle. Virus-like particles resembling
either EBOV or LASV were found to contain less surface PS when produced in cells deficient in scramblase
activity, also supporting our overall hypothesis that cellular enzymes involved in the production and localization
of PS will impact EBOV and LASV entry and spread. We have proposed three specific aims to further examine
the role PS plays in viral replication: Aim 1: Examine the requirements for cellular scramblase activity in EBOV
and LASV entry and virion production; Aim 2: Examine the requirements for cellular flippase activity in EBOV
and LASV entry; Aim 3: Determine the effects of altered cellular PS to EBOV and LASV replication and the
viral lipid profile. Using VSV-based pseudoparticles in addition to virus-like EBOV particles and recombinant
lymphocytic choriomeningitis virus (rLCMV) containing the LASV-GP, we will determine the role of cellular
flippases and scramblases during viral replication, and confirm our results using similar experiments with
authentic virus in a BSL4 lab. Experiments will also define the lipidome of these viruses and approaches will
focus on quantifying the levels of modified PS on viral particles. Understanding the role PS and other lipids
play on LASV and EBOV infectivity will potentially provide new targets for future antivirals.

Public health relevance
Project Narrative Phosphatidylserine is a lipid linked to efficient virus entry, yet we do not currently understand the step(s) in the viral replication cycle that require this lipid. This project will examine the role phosphatidylserine plays in entry and budding of hemorrhagic fever viruses, as well as identify additional lipids needed for virus replication. Understanding the interplay between cellular lipids and virus replication may provide new targets for developing antivirals.